Statistical methods to delineate the spatial and temporal pattern of cell-cell interactions in Spatial Transcriptomics data

PROJECT SUMMARY
Although studies of cell-cell interactions (CCIs) have attracted substantial attention from researchers to
understand cellular development and related disease onset, considerable methodological gaps remain in
assessing CCIs and their intra-sample heterogeneity in spatial transcriptomics (ST) data. This proposal is
driven by our collaborative work with biologists and physicians to investigate spatially heterogeneous CCIs and
their implications across various human diseases. The primary objective of this proposal is to develop robust
statistical methods to quantify the heterogeneous CCI patterns on ST platforms and identify spatial or temporal
differentially behaved CCIs across conditions. The project is structured around three complementary research
directions. 1) We propose a novel statistical model for ST data to estimate spatial CCI patterns, overcoming
limitations in existing methods. This model specifically accounts for spot-level cellular compositions and spatial
location information. We will extend this model to a population scale to identify CCI patterns with differential
heterogeneity across subjects with varying disease conditions. 2) We aim to incorporate spatial and temporal
constraints into statistical models to detect differential CCI patterns in longitudinally collected ST data. This
optimized approach will improve CCI quantification by modeling subject-specific patterns and leveraging ST
data from multiple time points. 3) We will generalize our statistical method by integrating serially sectioned ST
data with histological images, providing a robust solution for 3D CCI analysis. The proposed methods will be
applied to ST data from pancreatic and gastric cancer patients at The University of Texas MD Anderson Cancer
Center, as well as brain samples from patients with early- to late-stage Alzheimer’s disease. While initially
motivated by studies of cancer and Alzheimer’s disease, these statistical methods are broadly applicable for
estimating intra-sample heterogeneity of CCIs in other disease contexts and in embryo development research.
Once validated, we will make all software packages developed in this project available to the wider research
community. The proposed methods will bring unprecedented analytical power to characterization of cellular
interactions in their surrounding environments, allowing for discovery of many hidden phenotypes that are
disease- or patient outcome-associated.

Public health relevance
This proposal addresses critical computational challenges in accurately assessing cell-cell interactions in spatial transcriptomics studies. Successful completion of this project will provide powerful statistical tools for integrative evaluation of cell-cell interaction patterns using spatial transcriptomics data, cellular compositions, and histological images. The companion software packages will facilitate the discovery of important cellular activity for early disease detection and the identification of novel therapeutic targets.